Annual Meeting of the International Behavioral Neuroscience Society

DESCRIPTION (provided by applicant): The purpose of this project is to secure funds to help defray the costs associated with the Annual Meeting of the International Behavioral Neuroscience Society (IBNS). This project is a renewal of our existing R13 grant that has been instrumental in vaulting the IBNS into a position of the premiere behavioral neuroscience society in the world. The Annual Meeting represents a main component of the society's mission. The meeting is a 4 day event where attendees (~150-200) are housed at or within close walking distance to the meeting site - fostering a close community for scientific exchange. The locations of the meetings are predominantly in the US mainland but every 3-4 years the meeting occurs at some international site to acknowledge its international members. The meeting is comprised of a series of special symposia, keynote addresses, oral and poster presentations and workshops for professional skill development. Student Travel Award winners are featured prominently in this program with their own session that is attended by all registrants of the meeting. There are no concurrent sessions or programs, again, fostering a sense of communal scientific exchange. In this application, funds are requested for five years in order to support the following components of the Annual Meeting;Young Investigator Travel Awards, Registration Costs for invited Symposium Speakers, Speaker's Fee for Keynote Speakers, and money to help defray the costs of Publication of Abstracts of the Meeting on the IBNS website.